Impact of Mitochondrial Lipidomic Dynamics and its Interaction with APOE Isoforms on Brain Aging and Alzheimers Disease

PROJECT SUMMARY
The pathogenesis of Alzheimer's disease (AD) remains elusive. Inheritance of the apolipoprotein (APO) E4 allele
is the strongest genetic risk factor for sporadic late onset AD, whereas the APOE2 allele is protective and the
most common APOE3 allele is neutral. While the mechanisms by which APOE4 modifies the risk of AD are not
fully elucidated, compelling evidence indicates that the pathogenic effects of APOE4 are mediated by lipid-
related pathways. Integrative multi-omics studies have consistently demonstrated the strong association of lipid
pathways with AD phenotypes and that APOE4 disrupts intra/intercellular lipid homeostasis in cellular, organoid,
and animal models as well as postmortem brain tissue from individuals carrying different APOE alleles with or
without AD. Intriguingly, emerging evidence suggests that specific species of lipids/metabolic alterations in
subcellular organelles, in particular mitochondria, lead to neurotoxicity and neurodegeneration. Mitochondria are
the powerhouse of cells and provide the energy to sustain vital cellular functions. Notably, brain contains two
major populations of mitochondria, the synaptic mitochondria that originate from the synaptic bouton of neurons
and the non-synaptic mitochondria that originate from neuronal and glial cell bodies. Lipidomic analysis indicates
that synaptic and non-synaptic mitochondria have distinct lipid profiles that regulate compartmental energy
metabolism in the brain. Importantly, dysfunction of mitochondria, especially synaptic mitochondria, is well
established as one of the earliest deficits in the progression of AD. APOE4 has been associated with increased
impairment of mitochondrial structure and function compared with APOE3 in various models and human patients.
However, whether APOE genotypes regulate the lipidome of mitochondria during brain aging and whether the
dynamic changes of mitochondrial lipidomes affect the progression of AD are unknown. We hypothesize that
mitochondrial lipidomic dynamics and its interaction with APOE4 drive pathogenic brain aging and AD. Three
independent yet interrelated specific aims are proposed to test the hypothesis, using both mouse models and
human brains and a combination of behavioral and pathological approaches, coupled with innovative targeted
and unbiased cellular, molecular technologies, including lipidomics, transcriptomics, and brain clearing and 3D
imaging. Aim 1 is to assess the impact of APOE isoforms on mitochondrial lipidomic dynamics associated with
brain aging in humanized APOE4 and APOE3 mice. Aim 2 is to elucidate the relationship between mitochondrial
lipidomic dynamics and the progression of cognitive deficits and amyloid pathology in APP/PS1 mice. Aim 3 is
to define the interaction of mitochondrial lipidome with different APOE isoforms and its relation to cognitive
function and AD pathology in human brains. The results are expected to uncover the impact of mitochondrial
lipidomic dynamics and its interaction with APOE on brain aging and AD, and identify novel targets/pathways
that can be harnessed as diagnostic biomarkers and/or for therapeutic development to defeat AD.

Public health relevance
PROJECT NARRATIVE Inheritance of the apolipoprotein (APO) E4 gene is the strongest genetic risk factor identified to date for late onset Alzheimer's disease (AD), an age-related debilitating brain disorder that afflicts more than six million Americans and their families. Although the mechanisms by which APOE4 modifies the risk of AD are not fully understood, compelling evidence indicates that the pathogenic effects of APOE4 are mediated by lipid-related pathways involving the cell's powerhouse – mitochondria. The present study aims to assess the impact of mitochondrial lipidomic dynamics and its interaction with different APOE isoforms on brain aging and the progression of AD and identify novel molecular targets and/or pathways that can be harnessed as diagnostic biomarkers and/or for therapeutic development to block pathogenic brain aging and AD.